EFFECTS OF GROWTH HORMONE ON BONE MINERAL METABOLISM

To determine whether endogenous growth hormone secretory rates correlate with bone density in black and white, male and female, adult and pediatric subjects.